U-RISE at Worcester Polytechnic Institute (U-RISE@Wπ)

Project Summary/Abstract
The mission of the proposed U-RISE at Worcester Polytechnic Institute (U-RISE@Wπ) is to develop a research
training and mentorship transdisciplinary program and strengthen our inclusive community to nurture the academic
success of our undergraduate students. The program will guide our undergraduate students — especially from
underrepresented (UR) populations — towards successful enrollment and completion of PhD programs in the
biomedical sciences and engineering with a fun, cohesive structure, and supportive research ecosystem. Our
objective is to bring together faculty from nine departments and leverage our project-based curriculum,
recognized as being the best for combining scholarly research with classroom instruction to meet our goals
through three intersecting specific aims: Aim 1: To create a framework for education: we will leverage
common curriculum elements spanning across multiple degree programs, involve course-based undergraduate
research experiences (CUREs) and individually mentored undergraduate research experiences (UREs), and
culminate in an intensive senior capstone URE. Each project contributes not only to the student’s knowledge
base, but also to research skills such as teamwork, time management, literature reviews, and communication,
both written and oral. Aim 2: To build a supportive community: our programs will build an inclusive community
through coaching, mentorship, personal development workshops, retreats, and cohort experiences. Aim 3: To
strengthen the WPI research ecosystem through training: we will enhance the WPI research experiences for
all students with an evidence-based tiered mentoring and coaching system for faculty and students and provide
training in communication, safety, responsible and reproducible research practices, and applying for fellowships
and graduate school. This program is needed at WPI to level the playing field. While we have made strong
progress in increasing the proportion and success of female students at our science, technology, engineering,
and mathematics (STEM)-focused institution, we have had less success with other UR groups in STEM. Most
notably, our Black students have expressed feelings of loneliness and a lack of sense of belonging and have a
disproportionately high failure rate. Our goal is to improve the retention and graduation rates of students from
these UR groups by creating small teams of undergraduate researchers, each with a Faculty and Peer Coach
dedicated to each student’s success, regardless of incoming level, background, and self-confidence. Our
evidence-based approach is focused on mentoring and training with the additional value of coaching methods
which provide guidance, feedback, and resources to help Trainees acquire necessary skills, cultivate their self-
efficacy, and achieve their goals outside of the mentored research and evaluation approach. Trainees will
continuously be guided – with mentorship and coaching – through to completion of undergraduate studies and
onto graduate and fellowship applications in research-focused biomedical higher degree programs.

Public health relevance
Project Narrative The proposed U-RISE at Worcester Polytechnic Institute (U-RISE@Wπ) interdisciplinary training program combines course-based and individual research experiences with structured mentoring and coaching to strengthen our inclusive community and nurture the academic success of undergraduate Trainees — especially from underrepresented populations. An integrated team of Coaches, faculty Advisors, graduate Mentors, and peers will provide guidance, feedback, and resources to help Trainees acquire necessary skills and cultivate their self- efficacy while seeing the fun and excitement of research so that they may achieve their goals toward successfully completing of PhD programs in the biomedical sciences and engineering. The U-RISE@Wπ Trainees will enhance the diversity of the national workforce as they contribute their perspectives, scientific innovations, discoveries, and skillsets to improve public health.